Brain response associated with parent-based treatment for childhood anxiety disorders

Currently, 50% of children do not benefit from evidence-based treatments for childhood anxiety disorders.
This R61/R33 application proposes to test whether a novel entirely parent-based psychosocial intervention for
childhood anxiety disorders engages amygdala-medial prefrontal cortex (mPFC) neural circuitry in the child's
brain, implicated in children's reliance on parents to reduce their amygdala reactivity and anxiety; and whether
changes in the target circuitry after treatment are associated with reductions in child anxiety.
The R61 study will randomly assign 90 children (ages 7-10yrs) with primary anxiety disorders to one of two
interventions: 1) Supportive Parenting for Anxious Childhood Emotions (SPACE), a novel completely parent-
based treatment with no direct child involvement, that reduces children's anxiety by reducing parents'
accommodation of their child's symptoms; or 2) Parent Educational Support (PES), a credible comparator
intervention that is also entirely parent-based and controls for treatment duration and parent-therapist contact,
but does not include any active modification of parental behavior. Before and after treatment, functional
magnetic resonance imaging (fMRI) will be used examine children's reliance on parents to engage the target
circuitry by comparing children's amygdala reactivity and mPFC connectivity in the presence of their mother
and in the absence of their mother. We expect SPACE to reduce child reliance on parental presence to reduce
amygdala reactivity, significantly more than PES. If this hypothesis is supported the R33 will be performed. The
R33 will randomly assign 136 children (7-10yrs) with primary anxiety disorders to one of two interventions: 1)
Parents participate in SPACE; or 2) Children receive cognitive-behavioral therapy (CBT), a standard of care
treatment of known efficacy. We will use before and after fMRI and multi-informant/multi-modal child anxiety
evaluations. We expect SPACE to reduce child reliance on parental presence to reduce amygdala reactivity,
significantly more than CBT; We expect target engagement in SPACE to be associated with child anxiety
symptom reduction; We expect SPACE will be feasible to deliver and acceptable to children and parents.
This study is innovative in several ways and has the potential for large clinical and scientific impact. It is
the first study to examine the impact of a psychosocial intervention on the neural circuitry of children with
anxiety disorders, and the first study to examine the effects of an exclusively parent-only intervention with no
child-therapist contact, on child brain circuitry. It will provide insight into the neurobiology of children's
dependence on attachment figures for anxiety reduction, a process that contributes to the impairment and
costs associated with childhood anxiety disorders. As many children are unable or unwilling to participate in
therapy, results supporting the promise of SPACE as an effective way to reduce childhood anxiety would help
to address a common barrier to treatment. Promising results from this study would provide the basis for a
larger scale R01 clinical trial, to investigate the efficacy of SPACE and mediators and moderators of its effects.

Public health relevance
This R61/R33 study aims to investigate whether a novel entirely parent-based treatment for childhood anxiety disorders engages child brain circuitry implicated in children's reliance on parents to reduce anxiety (R61), and whether change in child brain circuitry is associated with reduction in child anxiety (R33). Results will lay the groundwork for a larger R01 clinical trial to test the efficacy of the treatment as well as mediators and moderators of treatment response.